High Salt Diet, Angiotensin II, and Microvessel Dilation

DESCRIPTION (provided by applicant): High salt (HS) diet leads to a dramatic and widespread impairment of vascular relaxation mechanisms and an impaired ability to regulate tissue perfusion in the absence of an elevated blood pressure. Angiotensin II (ANG II) suppression in response to HS diet is a crucial factor contributing to impaired vascular relaxation, since this effect can be prevented by chronic i.v. infusion of a subpressor dose of ANG II to prevent salt-induced suppression of plasma ANG II. An unexpected finding is that impaired vascular relaxation in rats fed HS diet is accompanied by an increased level of oxidative stress that can also be prevented by ANG II infusion. This action of ANG II appears to be mediated via transactivation of the EGF receptor, because it can be mimicked by infusion of EGF, and the protective effect of both ANG II and EGF to restore vascular relaxation in animals on HS diet can be prevented by inhibiting the EGF receptor or the ERK 1/2 pathway. The goal of this renewal application is to elucidate the mechanisms by which ANG II restores vascular relaxation in rats fed HS diet (with special emphasis on the role of EGF receptor transactivation and the ERK 1/2 pathway in maintaining vascular relaxation and normal antioxidant defense mechanisms). Our fundamental hypothesis is that impaired vascular relaxation in rats fed HS diet is due to an increase in vascular oxidative stress resulting from down regulation of antioxidant enzymes such as copper/zinc superoxide dismutase (Cu/Zn SOD), and possibly upregulation of pro- oxidant enzymes. We further hypothesize that ANG II exerts its protective effect to maintain normal vascular relaxation via transactivation of the EGF receptor, leading to increased expression of antioxidant enzymes, e.g., Cu/Zn SOD. The Specific Aims of this project are to: 1) evaluate the role of ANG II and EGF receptor transactivation in preventing oxidative stress and maintaining normal vascular relaxation mechanisms via the ERK 1/2 pathway; 2), evaluate the role of ANG II and EGF receptor transactivation in regulating the expression of pro- and antioxidant enzymes via the ERK 1/2 pathway; and 3) evaluate pro- and anti-oxidant enzyme activity in vessels from rats fed LS and HS diet, and to determine the effect of restoring plasma ANG II levels on the activities of these enzymes. The studies proposed in this application could open an entirely new area in the understanding of the physiological roles of ANG II, namely the maintenance of normal vascular relaxation by preventing oxidative stress in resistance arteries. PUBLIC HEALTH RELEVANCE: A growing body of evidence indicates that elevated dietary salt intake leads to dramatic alterations in vascular function without an increase in blood pressure. Many of the vascular changes occurring in rats and other species fed high salt diet are reminiscent of pathological alterations seen in vascular diseases such as hypertension, atherosclerosis, and hypercholesterolemia. Impaired vascular function with high salt diet appears to be mediated by increased oxidative stress in the blood vessels and suppression of the hormone angiotensin II (ANG II). This project will test the hypothesis that ANG II suppression leads directly to increased oxidative stress via down-regulation of antioxidant defense mechanisms in the blood vessels. These studies should provide valuable insight into the early changes occurring in response to high salt diet prior to elevation of blood pressure in salt sensitive hypertension, as well as the pathological changes that occur in response to elevated dietary salt intake.

Public health relevance
Narrative A growing body of evidence indicates that elevated dietary salt intake leads to dramatic alterations in vascular function without an increase in blood pressure. Many of the vascular changes occurring in rats and other species fed high salt diet are reminiscent of pathological alterations seen in vascular diseases such as hypertension, atherosclerosis, and hypercholesterolemia. Impaired vascular function with high salt diet appears to be mediated by increased oxidative stress in the blood vessels and suppression of the hormone angiotensin II (ANG II). This project will test the hypothesis that ANG II suppression leads directly to increased oxidative stress via down-regulation of antioxidant defense mechanisms in the blood vessels. These studies should provide valuable insight into the early changes occurring in response to high salt diet prior to elevation of blood pressure in salt sensitive hypertension, as well as the pathological changes that occur in response to elevated dietary salt intake.